Identifying and targeting gut microbial mechanisms that contribute to methotrexate response in rheumatoid arthritis

Low-dose methotrexate (MTX) is first-line therapy for millions of patients with inflammatory arthritis or
skin disease, but as many as 50-70% of patients do not adequately respond to MTX. A study of the Veterans
Affairs Rheumatoid Arthritis registry demonstrated that the mortality rate among veterans with RA is more than
double the rate of those without RA, which highlights the need for adequate treatment in this population.
Modifying factors that limit MTX response would enable more patients to benefit from this anchor drug that
synergistically increases the efficacy of other immunomodulatory medications. We recently showed that the gut
microbiome of rheumatoid arthritis (RA) patients predicts MTX responsiveness, raising the possibility that gut
microbiota contributes to MTX response. Unexpectedly, we found that MTX, originally designed to inhibit human
folate enzymes, exerts growth-inhibitory effects on gut microbiota, and transplantation of MTX-exposed
microbiotas into gnotobiotic mice led to decreased immune activation. Our findings suggest that one mechanism
by which MTX exerts its anti-inflammatory effects is via modulation of the gut microbiota. Thus, the gut
microbiome may be a modifiable factor that can be targeted to enable more patients to benefit from MTX.
There is, therefore, a critical need to identify microbial genes responsible for sensitivity to MTX and
mechanisms by which MTX affects the microbiota to shape host immunity to determine how to enhance MTX
response in the host. This information can enable us to potentially modify the microbiota and better target MTX
therapy to advance precision medicine for RA patients. The long-term goal of our lab is to identify the molecular
mechanisms by which the human gut microbiome impacts the treatment of rheumatic and autoimmune diseases
and determine how modulation of the microbiome can enhance therapeutic responses.
The overall objectives of this application are to (i) identify microbial genes that determine the sensitivity
of microbiota to MTX and (ii) and evaluate the mechanisms by which MTX acts on microbes to affect host
immunity. We will test the hypothesis that targeting bacterial pathways involved in antibiotic resistance and folate
metabolism can increase bacterial sensitivity to MTX, leading to increased extracellular adenosine and reduced
inflammation in the host. The rationale is that identifying these mechanistic links is critical to determine a scientific
framework for development of microbiota-targeted therapies to improve patient response to MTX. Using an
innovative combination of microbial genetics and genomics, bacterially targeted drug therapies, gnotobiotic
mouse models, and studies of patient-derived microbiotas, we first aim to (1) identify genetic determinants of
MTX sensitivity in bacteria, and (2) decipher mechanisms of immunomodulation by MTX-altered bacteria. This
project is significant because MTX non-response affects a majority of those tried on MTX. This project is
innovative because it systematically probes drug-microbiota interactions to determine contributions to MTX
response in the host. The results from these studies are critical to lay the foundation for the development of
microbially-directed therapies to improve MTX response, potentially enabling a greater number of patients to
benefit from an anchor drug in rheumatology.

Public health relevance
Rheumatoid arthritis (RA) is relevant to veteran’s health given the increased number of women veterans and the increased risk for RA with posttraumatic stress disorder. A study of the Veterans Affairs Rheumatoid Arthritis registry demonstrated the mortality rate among veterans with RA to be twice that of veterans without RA. Our recent studies indicate that the gut microbiome plays important roles in RA treatment and that MTX acts on the microbiota to reduce inflammation. Our studies will examine microbiota in veteran RA patients starting methotrexate and utilize these samples to elucidate the molecular mechanisms by which MTX acts on the microbiota. Doing so will lay the groundwork for development of a precision medicine approach that will enhance treatment response to MTX.